Technology Core

Project Summary: Technology Development Core
The long-term goal of the Johns Hopkins Center for Innovative Diagnostics for Infectious Diseases (JH-C[ID]2)
is to accelerate infectious disease diagnostic point-of-care (POC) technology innovation and access to impact
global public health. This is an unprecedented time for infectious disease (ID) diagnostics. The COVID-19
pandemic and the influx of funding from the Rapid Acceleration of Diagnostics (RADxTech) has stimulated and
accelerated the development of POC SARS-CoV-2 diagnostics. Some of these POC platforms could be used
to detect a wide range of other ID pathogens including STI and other emerging and re-emerging infections with
a relatively small additional investment. The technologic advances of the last decade have also brought new
innovation that could be leveraged for infectious disease diagnostics to create POC or self-tests that could be
cheaper, more robust, and faster. The JH-C[ID]2 has engaged with over 100 companies for STI and SARS-
CoV-2 POC tests (POCT) and has identified common bottlenecks to development to commercialization and
adoption. We have successfully moved several early-stage companies from proof-of-concept to FDA
clearance. Furthermore, developers who had worked with the JH-C[ID]2 on STI diagnostics were able to pivot
to SARS-CoV-2 detection as part of RADx Tech and complete development to achieve FDA emergency use
authorization. With our experienced, multi-disciplinary team, the Technology Core has the following aims: 1)
outreach to and calls for proposals from developers at all stages that target unmet need in infectious disease
diagnostics; 2) funding for meritorious proposals with clear milestones and decision points for go/no-go
decisions; 3) integrated evaluation and support from experts to decrease complexity and cost while identifying
risks to success through a systems engineering approach; 4) referral to Clinical Core services and other JH-
C[ID]2 resources to verify performance with clinical samples in the hands of potential users. Over the last 3
cycles and now in this cycle, we will continue to refine our development approach of multidisciplinary
innovation towards value-based adoption of accessible POC infectious disease diagnostics that will have
public health impact in different global settings.